GRP78 signaling and retinal angiogenesis

Retinal neovascularization (RNV) is one of the major factors in vision loss, particularly in diabetic patients. In
fact, WHO reported that by 2040, out of 642 million people with diabetes globally, 35% (224 million) of them
will develop some form of diabetic retinopathy, and 11% (70 million) will suffer with sight-threatening
retinopathy. The animal models mimicking retinal vasculopathies identified a dominant role for VEGF, which
subsequently led to the development of anti-VEGF therapies targeting RNV. However, these anti-VEGF
therapies are not selective in inhibiting RNV alone, as they also affect developmental and reparative
angiogenesis. Furthermore, long-term use of anti-VEGF regiments can cause degeneration of normal blood
vessels and angiofibrosis of neural retina and choroid resulting in vitreous hemorrhage. Therefore, it is
necessary to find therapeutics that target only pathological but not physiological signaling of VEGF. To this
end, we found that GRP78 was induced robustly by OIR and possessed the capacity to influence RNV. GRP78
is the main regulator of ER stress-induced unfolded protein response (UPR). In addition to its role in UPR,
GRP78 has been shown to be involved in tumor cell survival, proliferation, and drug resistance. Besides, a
correlation between GRP78 levels and RNV has also been reported. However, a causal link between these
two events is unknown. In this regard, our preliminary results revealed that GRP78 not only was induced by
OIR but also its conditional deletion in ECs reduced hypoxia-induced RNV. Furthermore, we observed that
GRP78 by triggering Wnt-independent release of b-catenin from adherent junctions and its complex formation
with STAT3 leads to cyclin D1 expression in enhancing EC proliferation and migration. Parallel to b-catenin-
STAT3-Cyclin D1 signaling, GRP78 via non-canonical NFkB RelB activation also mediates IL-8/Cxcl1/2
expression in the modulation EC sprouting. Based on these novel observations, we hypothesized that GRP78
plays a crucial role in RNV. We will address this major hypothesis by testing the following three specific aims.
Aim 1. UPR-independent activation of ATF6-GRP78 signaling is essential for VEGF/OIR-induced retinal
neovascularization; Aim 2. GRP78-mediated Wnt-independent activation of b-catenin is required for
VEGFA/OIR-induced cyclin D1 expression and retinal neovascularization; and Aim 3. Non-canonical NFkB,
RelB-mediated IL-8 expression is required for VEGFA/OIR-induced retinal neovascularization. The outcome of
these studies may identify selective drug targets for the treatment of RNV, including proliferative diabetic
retinopathy.

Public health relevance
Retinopathies, proliferative retinopathies, and age-related macular degeneration are the leading causes of vision loss. Major factors associated with these diseases are the development of new blood vessels that are non-productive and vulnerable to hemorrhage. Therefore, understanding the mechanisms underlying the abnormal blood vessel development may identify novel target molecules that may lead to the development of selective therapeutics against these ocular diseases.